Mentoring translational scientists in international infectious disease research

Abstract
Dr. Greenhouse is a physician scientist trained in internal medicine, infectious diseases, and
biostatistics. Over the past 18 years, he has worked across domains of field epidemiology, laboratory science,
data science, and public health to investigate the epidemiology of infectious diseases, with a focus on disease
transmission and development of immunity. His growth as a scientist and mentor was substantially accelerated
due to the dedicated time afforded by his current K24. Studies to accomplish the research aims outlined in his
prior K24 application have all been published as peer-reviewed papers and/or are the subject of active, R01-
level NIH grants where he or a clinician scientist that he mentors serves as principal investigator. During this
project period he published 80 papers, was PI on 3 new grants including R01 and U01 awards from NIAID,
was co-investigator on 6 new grants, and was primary mentor for 2 new K awards. Regarding mentorship, he
supervised 39 trainees including 14 from low- or middle-income countries, cofounded the UCSF EPPIcenter as
a center of excellence for research and training in patient-oriented research, created two longitudinal training
programs in malaria genetic epidemiology for African scientists, and co-led 3 workshops in genomic
epidemiologic analysis for over 100 African scientists.
During the next K24 project period, Dr. Greenhouse proposes to 1) focus on leadership development so
he can better guide the growth and success of the EPPIcenter; 2) expand the scope of his research portfolio to
include pathogens beyond malaria and the addition of domestic research; and 3) establish an interactive,
online training platform in genomic epidemiologic analysis. He presents a plan for achieving these goals by
obtaining leadership development training, expanding his skill set in the epidemiology of respiratory viruses
and laboratory methods for multi-pathogen surveillance, and developing expertise in curricular development
and other principles such as the use of technology for effective teaching. Dr. Greenhouse’s existing research
portfolio provides a wealth of opportunities for trainees, including projects studying the longitudinal
development of naturally acquired immunity to malaria using birth cohorts to simultaneously study the
pathogen and the host; systems immunology and computational analysis to comprehensively characterize
factors associated with development of immunity to malaria; and an array of projects related to the genomic
epidemiology of malaria including multiple with explicit training and capacity building goals. He proposes to
expand the scope of his research portfolio with 3 specific aims: 1) to develop and apply amplicon sequencing
tools to solve current challenges in malaria surveillance; 2) to characterize the pathogen landscape of non-
malarial febrile illness in Uganda; and 3) to characterize the transmission of respiratory pathogens in an urban
immigrant community in San Francisco.

Public health relevance
Project Narrative Becoming a successful translational scientist in the field of international infectious diseases is challenging, requiring extensive training in leading field studies, developing and performing laboratory assays, and synthesizing and interpreting the data generated. This K24 renewal will provide Dr. Greenhouse protected time for mentoring and career development, allowing him to help train the next generation of scientists in this area, drawing upon his broad expertise and established research program. He will focus on leadership development, expand the scope of his research portfolio beyond malaria, and establish an interactive, online training platform in genomic epidemiologic analysis.